HIVR4P 2023, the 5th HIV Research for Prevention Conference, Lima, Peru, and virtually, 22-26 October 2023

Project Summary
UNAIDS set ambitious prevention goals and targets for HIV incidence reductions for 2020. We were not on a
trajectory for success for those goals before the COVID-19 pandemic, and are at risk of further expansion of HIV
epidemics. Declines in surveillance capacity also threaten our ability to assess HIV epidemic trajectories in many
settings of risk. We face daunting challenges of ongoing transmission, and of growing gaps and disparities in
primary prevention. Yet the existing and expanding toolkit for biomedical prevention of HIV infection has never
had as much diversity, and as many high efficacy options, as today. Adolescents and younger adults in African
settings and in key populations globally continue to bear the greatest burdens of HIV incidence, and to have the
greatest challenges using and benefitting from biomedical HIV prevention advances. This population will be at
the center of HIVR4P 2023. A particular focus will also be made on people who inject drugs or who use
substances in sexual settings and have been understudied and underserved in HIV prevention. In the field of
HIV vaccines, the COVID-19 pandemic highlighted new threats in terms of vaccines hesitancy. It is time now to
investigate and report on new ways to addressing hesitancy and to understanding barriers to the uptake of novel
HIV vaccines, prevention technologies and approaches.
HIVR4P 2023, the 5th HIV Research for Prevention Conference taking place from 22 to 26 October 2023 in
Lima, Peru, will be an opportunity for the HIV prevention community to hear, debate and weigh new scientific
evidence, and to assess the increasingly complex prevention landscape and the next generation of research
questions, including those for HIV vaccines, and the interactions of vaccines with non-vaccine prevention
modalities. Lima was chosen as the host city to highlight scientific excellence in prevention research in the Latin
American region while also drawing attention to the spiraling vulnerabilities and epidemics in the region.
To facilitate everyone’s access to the conference regardless of their ability or willingness to travel, and
recognizing that potential obstacles - including access to COVID-19 vaccines - might prevent key stakeholders
particularly from countries with a high burden of HIV from travelling internationally, HIVR4P 2023 will be a fully
hybrid conference. It will connect the two audiences both in Lima, which will provide a compelling venue for
HIVR4P 2023 as a leading center of HIV prevention science, and online via the virtual conference platform.
Specific aims for HIVR4P 2023 are to:
1. Convene the world’s experts in HIV prevention and related fields to advance scientific knowledge,
present new research findings, and enhance global scientific and community collaborations
2. Advance HIV prevention technologies and implementation approaches that are tailored to the needs of
those most at risk including adolescents and young adults, men who have sex with men, people who use
drugs, sex workers, and transgender people globally, and women and girls in high-burden settings
3. Refine HIV prevention research agendas to reflect identified opportunities and knowledge gaps, including:
Next generation HIV vaccines and bNAbs; hesitancy and misinformation; smarter delivery systems for small
molecules, including longer-acting PrEP, depo formulation and multi-purpose technologies
4. Assess the state of the art of HIV vaccine research in light of the remarkable success of the COVID-19
vaccine enterprise, including the role of non-vaccine interventions in the next generation of HIV vaccine
efficacy trials.
The scientific program will consist of five thematic areas: basic science; PrEP and ARV-based prevention;
Vaccines and bNAbs clinical trials; other prevention modalities and cross-cutting issues; applied and
implementation science. The scientific program is developed by a multi-disciplinary international Organizing
Committee. Cross-cutting aspects will be highlighted in plenary talks that also connect the science with
community and leadership perspectives. Additionally, bridging sessions are designed to cut across the different
thematic areas to provide opportunities for multi-disciplinary, multi-perspective dialogues, often using interactive
formats. The participation of young researchers, basic scientists and researchers in related fields will be
strengthened by active solicitation of relevant science and the provision of specific financial support, in addition
to remote-access options. Key science from the conference will be disseminated and discussed in regional
contexts following HIVR4P 2023.

Public health relevance
Project narrative HIVR4P 2023, the 5th HIV Research for Prevention Conference, will be held from 22-26 October 2023 in Lima, Peru, and virtually, with an expected attendance of 1,600 delegates (1,000 in person and 600 virtually). The conference will be the key global scientific convening to reflect on the state of HIV prevention, recalibrate priorities, and map out a work plan for the coming decade. It will not only be the opportunity for the HIV prevention community to gather, debate, weigh evidence, and assess an increasingly complex prevention landscape. It will also constitute a key forum to explore and address the question of the next generation of research. Adolescents and younger adults in African settings and in key populations globally, who continue to bear the greatest burdens of HIV incidence and face the biggest constraints in terms of using and benefitting from biomedical HIV prevention advances, will be at the center of deliberations and discussions. HIVR4P 2023 will be a fully hybrid conference, offering quality access to conference content and engagement opportunities to in-person and virtual participants alike.